Healthy Brain and Child Development National Consortium Data Coordinating Center

PROJECT SUMMARY
The landmark Healthy Brain and Child Development (HBCD) study will provide a representative reference data
resource to the scientific community enabling unprecedented investigation of neurodevelopment and the impact
of environmental, genetic, and biological factors on brain and behavioral health and developmental trajectories
from infancy through childhood. Through this study, the Healthy Brain and Child Development Consortium will
recruit and retain a cohort of approximately 7,200 pregnant women from 24 sites across the U.S. and follow
these families and their children through the first decade of life. Children will undergo rigorous data collection
across modalities including neuroimaging, neurophysiology, behavioral and cognitive assessments, and
collection of biospecimens via a balanced protocol developed by field-leading experts. Building upon the
substantive complementary experience and expertise of its multidisciplinary team and leveraging multiple
population-specific technical innovations, the Healthy Brain and Child Development Data Coordinating Center
(HDCC) will provide the leadership, management, and oversight of data collection, quality control, curation,
processing, management, sharing, and analytics to facilitate and support the activities of the HBCD Consortium
and ensure its success. Included is development and implementation of an optimized, state-of-the-art MRI
protocol harmonized for the first time in infants/toddlers across all three major vendors which leverages the latest
innovations in scanner technology with age-specific structural, microstructural, quantitative, functional, and
spectroscopy sequences. Also detailed is a targeted EEG protocol linked with a field-leading automated
processing pipeline for developmental EEG which provides innovative derivative measures. Data and project
management will occur through a centralized tracking and distribution platform linked to a high-throughput
compute backbone which overcomes limits of commercially-available systems for management and integrated
processing of multimodality data from large, multi-site studies. High performance computing will be supported
through unique access to a combination of field-leading resources. Detailed procedures are outlined for secure
collection, management, and analysis of personally identifiable information (PII) data, including flexible methods
designed to accommodate heterogeneity in electronic health record systems across sites. Finally, substantive
HBCD-specific enhancements to the Data Exploration and Analysis Portal (DEAP 2.0) will produce a crucial tool
for data access to authenticated users while promoting best practices in reproducible statistical analysis and
providing flexible computation without the need to download restricted-access data. The result of this field-
leading combination of HDCC resources will be a state-of-the-art, longitudinal data set of unparalleled scale
which provides deep understanding of the biological and environmental factors that affect a child’s health, brain,
and behavioral development and shapes research, clinical care, and public policy for decades to come.

Public health relevance
PROJECT NARRATIVE The Healthy Brain and Child Development (HBCD) study will encompass data collection from a cohort of 7,200 parent-child dyads across 24 independent U01 sites over a range of modalities including harmonized neuroimaging, neurophysiology, behavioral and cognitive assessments, and the collection of biospecimens. This administrative supplement will enable the HBCD Data Coordinating Center to fully support successful and coordinated data collection and release activities across the Consortium through the accommodation of required and unplanned costs secondary to evolving study workflows and increasing site support needs, opportunities to incorporate new data types into HBCD, adherence to guidelines related to data sharing, and modality-specific technical requirements for data analysis and release.